2/2 CORD-CHD: Clamp OR Delay among neonates with Congenital Heart Disease

PROJECT SUMMARY/ABSTRACT
Clamping and cutting the umbilical cord is the most common intervention in humans, occurring in 140 million
annual births. To maximize expediency (manage 3rd stage of labor, initiate neonatal resuscitation), early cord
clamping (ECC) is performed within ~30 sec of delivery. Recently, evidence has emerged on the health benefits
of delayed cord clamping (DCC, waiting ~1-2 min before clamping). Among term neonates, multiple randomized
controlled trials (RCTs) have shown that DCC transfers blood from placentas to newborns, resulting in less iron-
deficiency anemia and improved neurodevelopmental (neuromotor) outcomes through 4 years, than with ECC.
Despite advantages for healthy newborns, in view of their exclusion from previous RCTs, the best approach to
cord clamping in higher-risk pregnancies, notably those complicated by a fetal diagnosis of critical congenital
heart disease (CCHD), remains uncertain. Although one might assume that the benefits of DCC in low-risk new-
born populations would translate simply to CCHD neonates, unique anatomic and physiologic differences in
neonates with CCHD suggest that risks of DCC in this subgroup may differ from risks in neonates without CCHD.
Thus, a treatment dilemma exists on the optimal cord clamping practice at birth among CCHD neonates. The
proposed study, entitled CORD-CHD (Clamp OR Delay among neonates with Congenital Heart Disease) trial
will be the first RCT to determine the effectiveness of DCC vs. ECC on postnatal and neurodevelopmental
outcomes of CCHD neonates. Our preliminary data demonstrate that, among CCHD neonates, DCC results in
lower global rank scores (GRS), indicative of better health outcomes, than ECC. GRS is a validated composite
measure, based upon the worst outcome post-cardiac surgery or catheterization and reflects the need for com-
plex intensive care. Given the absence of high-quality data, maternal outcomes will also be determined. We will
leverage a network of sites with requisite infrastructures, established guidelines with high adherence rates and
treatment fidelity, and track records of collaboration. Aim 1 is to test the hypothesis that, among CCHD neonates,
DCC results in lower GRS (better outcomes) post-cardiac surgery or catheterization, based on a higher win-odds
(win-ratio adapted to include ties), than with ECC. Aim 2 is to test the hypothesis that, among neonates with
CCHD, DCC will result in better neuromotor outcomes at 22-26mos postnatal, based on a joint test of a bivariate
outcome (Developmental Assessment of Young Children Second Edition motor score and the Hammersmith
Neonate Neurological Exam) than with ECC. As a secondary objective, we will test the hypothesis that among
CCHD neonates improved neuromotor profiles (General Movement Assessment) at 3-4mos mediate improved
neuromotor outcomes at 22-26mos. Aim 3 is to precisely estimate the difference in the risk of maternal postpar-
tum hemorrhage between DCC and ECC to evaluate safety among mothers who give birth to CCHD neonates.
This trial will advance the care of CCHD neonates and provide the evidence called for by national and interna-
tional organizations, creating a global impact on umbilical cord management among a vulnerable population.

Public health relevance
NARRATIVE: Clamping and cutting the umbilical cord at birth occurs for each of the 140 million neonates born annually. The significant public health advantages of delayed cord clamping (DCC) over early cord clamping (ECC) for healthy newborns has not been studied in neonates with critical congenital heart disease (CCHD), a population with a high frequency of adverse outcomes and, correspondingly, the potential for substantial benefit from ameliorative interventions. The studies described in the present proposal are relevant to NIH's mission to understand the processes of human growth and development, by determining, via a multicenter randomized clinical trial, whether, among neonates born with CCHD, DCC provides better outcomes post cardiac surgery or catheterization, as measured by a validated composite measure (global rank scores) and neurodevelopmental outcomes, than are observed with ECC.